Realtime visualization and analytics of epigenomic data using a serverless architecture

PROJECT SUMMARY Epigenetics describes the study of phenotypic outcomes due to alterations in gene expression without changes to the coding DNA. The field has exploded in the past decade with the recognition that epigenetic factors (e.g. histone post-translational modifications, chromatin-associated proteins, DNA methylation) regulate gene expression and diverse downstream cellular processes, including the development of human disease. Next Generation Sequencing (NGS) studies of these epigenetic changes have enabled a more fundamental understanding of how chromatin structure impacts human health and revealed new targets for drug development. The importance of this field has driven remarkable advances in epigenomic profiling; however, innovations in methods to intelligibly interpret, compare, and visualize this mass of epigenetic data have lagged behind. The current framework for these tertiary analyses is slow, too technical for most users, and unable to process the increasingly complex queries that are required for epigenetic discovery. Basepair® is an industry leader in streamlined NGS analysis pipelines. Here, we will leverage this expertise with the development of EpiBeacon?, a serverless, user-friendly platform for rapid tertiary analysis of epigenetic data. In Aim 1, we will develop the EpiBeacon platform using the Amazon Web Services (AWS) Lambda service to instantly generate heatmaps of chromatin profiling data sourced from ENCODE. EpiBeacon will be uniquely compatible with the multiple rounds of iterative sampling required for tertiary analysis, and users will be able to dynamically adjust heatmap parameters and produce publication-ready figures in real time. In Aim 2, we will enable EpiBeacon with more sophisticated comparative analysis capabilities, which we will apply to answer an emerging problem in the field: whether antibodies and data from Chromatin ImmunoPrecipitation followed by NGS (ChIP-seq) are applicable to the novel chromatin profiling technology, CUT&RUN. CUT&RUN has the potential to supersede ChIP-seq as the standard in chromatin profiling, as it produces higher resolution data with fewer reads and reduced cell input vs. ChIP-seq. However, the methods underlying each approach are strikingly different, and antibodies that perform well in ChIP-seq may not be successful in CUT&RUN. We will work with EpiCypher®, a leader in chromatin technology development, to compare H3K4me3 and H3K27me3 antibody performance across ChIP and CUT&RUN experiments. The success of this Aim will validate EpiBeacon for comparative chromatin analyses and provide essential information for scientists adopting CUT&RUN. In Phase II, EpiBeacon will be expanded to other analyses (e.g. pathway analysis, motif discovery), other epigenomic assays (e.g. ATAC-seq), launch new tools to integrate multiple data sets (e.g. ChIP-seq and RNA- seq), and leverage publicly available datasets (e.g. NCBI SRA), which hold a wealth of epigenetic data that have been challenging to utilize with existing software. EpiBeacon will thus deliver the most rapid and user-friendly tertiary NGS analysis platform on the market, driving epigenetic discovery for advanced biomedical applications.

Public health relevance
PROJECT NARRATIVE Epigenetic changes (i.e. modifications in chromatin architecture) impact the development of numerous diseases, most notably cancer, and are being increasingly targeted in next-generation sequencing (NGS) studies. This wealth of data has driven striking improvements in the speed and user-friendly quality of secondary bioinformatics pipelines; however, similar innovations for tertiary analysis, including study / sample comparisons and data visualization are lacking. Basepair®, an industry leader in NGS pipelines, will develop EpiBeacon™, a serverless platform for real time and advanced comparative analyses that will provide users with unprecedented dynamic visualization of data and drive future epigenetic discovery.